APPLICATION OF ION COMPLEXES TO POLYENE SYNTHESIS: IRON

Synthesis of Macrolactin A, Protomycinolide IV and ambruticin using dieneand dicnyl-iron complexes. Analysis by mass spectrometry necessary for complete product characterization.